Multi-level mechanisms and predictors of irritability: An innovative approach bridging laboratory and real-world measures

PROJECT SUMMARY/ABSTRACT
Irritability, an increased propensity to experience anger and frustration, is among the most common presenting
complaints in child psychiatry. Severe irritability affects up to 10% of youth in the U.S. and causes significant
impairment and high rates of service use and school suspensions. Normative irritability follows a low, declining
trajectory from childhood to adolescence. However, some youth remain persistently, highly irritable over
development, putting them at the greatest risk for later psychopathology and adverse outcomes, including
depression, anxiety, and suicidality. Currently, there are no evidence-based treatments for chronic irritability.
This is because of the limited understanding of the etiology and mechanisms of chronic irritability. This New
Innovator application addresses this significant gap by identifying predictors and mechanisms of chronic
irritability trajectory across multiple levels of analysis including the brain, physiology, behavior, social experience,
and family/environment. Specific goals of this project are to (1) identify neural markers (i.e., brain function and
connectivity) that predict which child will follow a chronic, persistently high irritability trajectory over time and the
developmental changes in these neural markers that underlie chronic irritability; (2) identify social and
environmental determinants of chronic irritability and their mediating effects on the link between neural alterations
and chronic irritability; (3) enhance prediction of chronic irritability using data from multiple levels of analysis
including the brain, physiology, behaviors, social experiences, and familial/environmental factors. We will
accomplish these goals in a 3-wave longitudinal functional magnetic resonance imaging (fMRI) study, with a
sample of 180 children with (n=120) and without elevated irritability (n=60) at ages 8–13 years. Multi-method,
multi-informant assessments will occur annually at three timepoints over two years. Parent-, youth-, and clinician-
reports will assess youth irritability. An innovative smartphone-based, naturalistic ecological momentary
assessment will measure irritability as well as parent-child and peer relationships/interactions in real time. fMRI
will be collected during a novel social vs. non-social FNR task, addressing a significant gap in the field by probing
the role of contexts in frustration-related neural alterations. Parent and youth will engage in two interactive tasks
in the laboratory (conflict discussion and solving difficult puzzles) while their behaviors and heart rates are being
measured. We will first chart within-person irritability trajectories over time using data-driven, person-centered
latent class growth mixture modeling, and then apply machine learning with the multi-level data to predict chronic
irritability trajectory at the single-subject level. This project, a significant leap forward from the current field, will
provide novel, important insights into the predictors and mechanisms of irritability trajectories across multiple
levels of analysis. Results will advance efforts toward development of evidence-based preventions and
interventions for irritability—a top problem in child psychiatry and a robust predictor of suicidality.

Public health relevance
PROJECT NARRATIVE This project uses innovative laboratory- and smartphone-based approaches to map out trajectories of irritability over a two-year period in youth ages 8–13 years and identify factors related to the brain, physiology, behavior, social experience, and family/environment that predict and explain why some children remain highly irritable over time. Results will provide insights into the risk and protective factors of chronic irritability in youth. This knowledge will help advance efforts toward development of evidence-based preventions and interventions for many pediatric disorders for which irritability is a prominent symptom.